IMMUNOPATHOGENESIS OF THYROID DISEASE

It is planned to continue investigations of the pathogenesis of autoimmune thyroid disease. Attempts will be made to learn how immunoregulation is disordered in order to permit a break in tolerance to self antigens. Studies will also be performed to learn by what means immune reactants induced thyroid disease. The hypothesis that the thyroid-stimulating, immunoglobulin (TSI) responsible for the hyperthyroidism of Graves' disease arises as an antiidiotype to anti-TSH will be investigated by seeking anti-TSH activity in serum containing thyroid-stimulating immunoglobulins and TSI in serum containing anti-TSH. In an attempt to learn more about the deranged immunoregulation responsible for autoimmune thyroid diseases, we will produce monoclonal autoantibodies by fusing patients' antibody-forming peripheral blood lymphocytes with myeloma cells to produce autoantibody secreting hybridomas. Monoclonal antibodies derived from such hybridomas will be used as immunogens to raise antiidiotypic sera. In a search for therapeutic approaches to autoantibody synthesis, we will further study antithyroglobulin synthesis in vitro by assessing the response of such synthesis to various drugs and chemicals.